Pathways to Hope: Pilot fMRI Study of OCPD and Suicide Risk in Trauma-Exposed Veterans

Project Summary/Abstract
In military culture, high standards are revered, yet negative aspects of overcontrol are often overlooked.
Overcontrol manifests as rigid behavior, cognitive inflexibility, and a strong need for perfection. It is
predominantly seen in obsessive-compulsive (OC) spectrum disorders, especially OC Personality Disorder
(OCPD). On the surface, overcontrolled individuals seem composed, but internally they are emotionally
turbulent. Their inclination to set high expectations for others often causes interpersonal tension straining
social bonds. When grappling with mental health challenges, overcontrolled individuals, often endure with
limited social support, resulting in more dire consequences. For example, Veterans exhibiting OC spectrum
traits are particularly susceptible to trauma-induced anger and have a heightened risk of suicide.
Treatments enhancements are urgently needed to improve interpersonal functioning, quality of life and mitigate
suicide risk these vulnerable Veterans. Neuromodulation adjunctive to psychotherapy is a promising option.
Key obstacles, however, impede the development of circuit-based treatments tailored to this phenotype: 1)
limited validation of existing associations between interpersonal functioning and OCPD in a broader,
overcontrolled sample, 2) the absence of a unified, transdiagnostic circuit model of overcontrol, and 3) robust
methods for tracking gradual changes in individuals’ functioning throughout the course of treatment.
This pilot project will develop methods to address these knowledge gaps. Specifically, we aim to 1) Assess the
feasibility of our recruitment strategy and evaluate interpersonal functioning in a cohort of trauma-exposed
Veterans exhibiting overcontrolled traits; 2) Test the feasibility and acceptability of a three-session, weekly fMRI
protocol focused on the circuitry of overcontrol, while evaluating within-subject reliability of observed neural
correlates; 3) Examine the feasibility and acceptability of a three-week protocol for remote monitoring of weekly
variance in socio-occupational functioning and emotional regulation.
This pilot initiates a multi-year research endeavor to reduce suicide risk by enhancing care for Veterans with
OCPD-like overcontrol. Our venture aims to position VHA Rehabilitation R&D as a leader in precision medicine
for those at risk of suicide due to cognitive overcontrol, perfectionism, and OC-spectrum disorders comorbid
with PTSD, anger, or depression. Our proposal aligns with the RFA's call for innovative suicide interventions,
including transformative neuromodulation strategies.

Public health relevance
Project Narrative This SPiRE pilot will provide foundational data paving the way for treatment enhancements tailored for Veterans with obsessive-compulsive spectrum disorders or an 'overcontrolled' temperament—a high-risk, underserved group vulnerable to suicide. Our longer-term goal is to enhance diagnostic precision and treatment effectiveness for veterans at elevated suicide risk due to these specific conditions.